Pre-clinical Bruker Albira Si PET/SPECT/CT imaging system

PROJECT SUMMARY/ABSTRACT
The Department of Radiology at the Stanford School of Medicine is a preeminent institution renown for
developing next generation imaging technology, molecular imaging, in vitro diagnostics, image-guided
therapeutics, and informatics for precision health. Our Molecular Imaging Program at Stanford (MIPS), a highly
regarded interdisciplinary research division established in 2003, brings together scientists and physicians who
share a common interest in developing and using state-of-the-art imaging technology and developing molecular
imaging assays for studying intact biological systems. There is now a pressing unmet programmatic need for a
multimodal small animal imaging system that offers state-of-the-art imaging available in the Bruker Albira Si
PET/SPECT/CT. It will be an enabling technology at Stanford, creating new research opportunities for multi-
tracer imaging, significantly broadening our repertoire of radionuclides beyond positron-emitters and accelerating
novel radiopharmaceutical development and clinical translation in our theragnostics program. It will allow
sunsetting of our once-state-of-the-art, but now end-of-life workhorse Inveon PET/CT, which has experienced
increasing downtime due to failures. It will be placed in our comprehensive small animal imaging facility as a
Stanford shared resource and supported by a team of PhD-level senior scientists. An integrated trimodal imaging
system will immediately contribute to our well-established and growing radionuclide-based biomarker discovery
program in diagnostics and radioligand therapy. The Major and Minor users we have assembled reflect junior
through senior faculty with NIH-funded research projects and includes highly accomplished experts in their fields.
They are particularly interested in multi-tracer applications and, therefore, an integrated system combining
SPECT, PET and CT is especially needed. The nuclear imaging modalities would support our researchers who
study image-guided drug delivery, cancer biology, neurological diseases, cancer cell and gene therapies, and
immunity and immunotherapy, in addition to developing novel diagnostic and theragnostic radiopharmaceuticals
and imaging strategies. SPECT is essential for researchers who need access to biomarkers outside of those for
PET and for imaging more than one target concurrently. Both modalities, when combined with anatomical CT,
are essential to advance novel radiopharmaceuticals from discovery to first-in-human clinical translation, and will
be central to our expanding theragnostics activities. The addition of this instrument will converge with
programmatic activities at Stanford: new state-of-the-art cyclotron and radiochemistry facility, first designated
comprehensive Radiopharmaceutical Therapy Center of Excellence, growing interest in theragnostics and
biomarker discovery, and new educational opportunities in biomedical physics, imaging and radionuclide-based
therapy. The Albira system will create novel opportunities in small animal research and synergize with Stanford’s
long-range vision to lead in biomedical innovation and advanced precision medicine.

Public health relevance
PROJECT NARRATIVE The Bruker Albira Si PET/SPECT/CT imaging system is an enabling technology for research in living subjects. It will enable functional imaging of multiple biological processes in the same subject at the same time and support small animal imaging research employing radiopharmaceutical agents for disease diagnosis and targeted radionuclide therapy. The system will bridge the translation of new imaging biomarkers validated in cells into pre- clinical animal models, and ultimately for clinical care.